Developing and evaluating bone targeting agents to mimic the skeletal effects of mechanical loading

Project Summary/ Abstract
Osteoporosis is a systemic skeletal disease characterized by low bone mass and microarchitectural
deterioration of bone tissue with a consequent increase in bone fragility and susceptibility to fracture. One in
three women and one in five men over the age of 50 years are predicted to suffer a fracture leading to
limitations in the quality of life, pain, morbidity, and increased mortality. However, it is difficult to treat most
diseases of the skeletal system with non-bone selective drug delivery. Visceral organs may be exposed to the
bulk of the pharmaceutical drug, while very low drug concentrations reach the bone compartment.
Mechanical loading is well known as a key factor that can increase bone formation and bone mass.
Astronauts lose bone mass during space flight due to reduced gravity and skeletal unloading. Recently, we
demonstrated that inhibiting FAK (Focal adhesion kinase) mimics the effects of mechanical loading in bone
cells (Sato et al. Nat Commun, 2020). However, FAK and its homolog, PYK2 are widely expressed in almost all
tissues and organs. Therefore, FAK inhibitor treatment may cause severe side-effects outside of bone. To
address this problem, we will develop bone-targeted FAK inhibitors via bisphosphonate (BP) conjugation.
This high-risk, high-reward proposal brings considerable potential benefit to the musculoskeletal research
field. (1) Bone targeting via BP-conjugation will eliminate extra-skeletal side effects of FAK inhibitors. (2)
Bisphosphonates can cause side effects such as osteonecrosis of the jaw and cytotoxicities. However, our
novel pharmacologically-inactive BP addresses this potential concern. (3) The BP-conjugates may increase
FAK inhibitors' efficacy to around 10 to 1000 times higher bone formation than the original because this
conjugation method delivers to the target sites and releases the active drug (FAK inhibitor) selectively at high
bone metabolic sites. (4) There can be no serum calcium elevation by BP-FAK inhibitors, although current
bone formation inducible drugs like teriparatide (PTH1-34) and abaloparatide (PTH analog). (5) FAK inhibitors
are under several clinical trials for certain cancer therapies. So, bisphosphonate-conjugated FAK inhibitors are
clinically relevant drugs as bone-specific bone formation induced agents. (6) This BP-conjugation can reduce
administration frequencies due to bisphosphonate biomaterial property that binds to hydroxyapatite and stays
on the sites. (7) Our new formulation strategies may be pursued to address oral availability limitations.
Aim 1 of this proposal will develop and evaluate BP-conjugated bone-targeting FAK inhibitor (VS-6063) in
vitro (osteoblasts, osteoclasts, and osteocytes). In aim 2, we will perform hindlimb unloading animlal model as
disuse osteoporosis to define the therapeutic action of FAK inhibitors in bone. This will offer thousands of new
candidate FAK substrates for the final development of a druggable BP-FAK inhibitor conjugate. Taken
together, these studies will develop novel bone-targeted pharmacologic agents to mimic mechanotransduction
and treat immobilization-induced bone loss.

Public health relevance
1 Narrative 2 3 Osteoporosis is a systemic skeletal disease along with fractures leading to functional limitations, pain, morbidity, and 4 increased mortality. However, it is difficult to treat most diseases of the skeletal system with non-bone selective drug 5 delivery. In this proposal, we will develop novel bone-targeted focal adhesion kinase inhibitors and evaluate the 6 efficacy of such agents in disuse bone loss. 7